Cardiac sURgery anesthesia Best practices to reduce Acute Kidney Injury (CURB-AKI)

Project Summary
Almost 300,000 patients undergo cardiac surgery in the U.S. annually, and up to 30% develop cardiac surgery
associated acute kidney injury (CSA-AKI). The complication is potentially preventable and results in 3-4
additional intensive care unit (ICU) days, $10-40K added health expenditures per case, and up to 10-fold
increased odds of mortality. In severe cases requiring dialysis, consequences are even greater. While efforts to
identify targets for CSA-AKI risk-reducing interventions have focused on underlying patient risk and surgical
details, the intraoperative and early ICU periods remain understudied sources of outcome variation.
Intraoperative and early ICU periods present unique opportunities for reducing CSA-AKI due to (i) unique renal
insults due to altered hemodynamics of cardiopulmonary bypass; (ii) major physiologic shifts and clinical
interventions detailed in granular intraoperative and ICU data, and (iii) amenability to process change.
A paradigm shift in how CSA-AKI is understood during these periods remains possible through the addition of
detailed minute-to-minute intraoperative and early ICU data to factors in traditional prediction models, but
requires advanced analytical approaches to identify patterns within the 25,000 physiologic, fluid, medication, and
intervention data points available for each patient. The potential value of such patterns is emerging in recent
studies, yet remains unvalidated in large, contemporary cardiac surgery populations. Moreover, for CSA-AKI
prediction models to be maximally informative, risk-reducing modifiable processes of care are likely not “one size
fits all”, as are commonly applied in healthcare despite important heterogeneity of treatment effects across
diverse pathologies and procedures. Finally, efforts to translate evidence to practice often fail, due to poor
communication of evidence-based, patient-specific benchmarking data to individual clinicians.
We propose a multicenter study leveraging the integration of two mature, unique research and quality
improvement collaboratives built upon national, standardized registries: the Multicenter Perioperative Outcomes
Group (MPOG) and the Society for Thoracic Surgeons (STS) Adult Cardiac Database. MPOG uses nurse-
validated, detailed minute-to-minute intraoperative and early ICU data from the EHR for research and quality
improvement. Headquartered at University of Michigan and guided by Associate Research Director PI Mathis,
MPOG has integrated 16 million patient records across >40 health systems in 22 states and provides monthly
automated performance improvement benchmarking reports to 5,000 frontline anesthesiology clinicians. In
addition, MPOG has integrated each member hospital’s STS clinical registry to create a unique national “MPOG-
STS” dataset of 80,000 cardiac surgeries. We will (i) identify high-impact, modifiable intraoperative and early
ICU processes of care associated with reduced CSA-AKI; (ii) estimate the impact of individualized treatment
strategies versus standardized or usual care for reducing CSA-AKI and progression to CKD, and (iii) disseminate
and assess the effect of precision feedback on CSA-AKI and relevant processes of care.

Public health relevance
Narrative / Public Relevance Statement Almost 300,000 patients undergo cardiac surgery in the US each year, and up to 30% develop cardiac surgery- associated acute kidney injury (CSA-AKI), increasing mortality by up to 10-fold and adding $10-40K to hospital expenditures per case. Beyond patient and surgical baseline characteristics, intraoperative and early postoperative ICU processes of care vary widely across hospitals and remain a critically understudied data source for developing a precision understanding of factors contributing to CSA-AKI. We will (i) identify modifiable intraoperative and early postoperative practices associated with reduced risk of CSA-AKI; (ii) estimate the most effective strategy for reducing CSA-AKI, comparing individualized care, standardized care, and usual care, and (iii) disseminate and assess the effect of precision feedback on CSA-AKI and relevant processes of care.